The Effects of Cue Precision on Medical Imaging Interpretation

PROGRAM SUMMARY:
It is undesirable for radiologists to search for only one specific thing at a time, as they
may miss unexpected findings. Despite this, there is evidence that prior knowledge and expectations (from
clinical history or other cues) alter radiologists’ search performance and diagnostic accuracy. As Artificial
Intelligence tools are added to the radiologic workflow, understanding the effects of different cues on radiologists
will be critical for optimizing the way information is presented to radiologists. Cues that precisely describe targets
(“find the red apple”) are known to guide search more efficiently than imprecise cues (“find the apple”). However,
this precision effect has only been explored in cases where hue differentiates targets from distractor objects,
which is not the case in radiology. And location cues (indicating where the target is) might increase both correct
responses and false alarms, though it is unclear what precisely drives those false alarms. Filling these gaps in
knowledge is critical for optimizing current and future systems that provide information to radiologists and other
medical imaging professionals. In a novel approach, this project will quantify the effects of precise vs imprecise
text cues and precise vs imprecise cues to target locations in radiologic search tasks while recording radiologists’
eye movements. The central hypothesis is that expert radiologists will search more effectively for abnormalities
and will identify nodules more quickly when provided with more information (precise features and/or location)
cues. The proposed project will precisely characterize the performance and gaze behavior of expert radiologists
as they view chest x-rays ( ) and 3D volumetric CTs (
Aim 1
Aim 2
). The research team will assess the effects of
cue precision and cues indicating nodule locations on accuracy in identifying abnormalities, time taken to look at
abnormalities, and changes in the radiologists’ overall strategies and other factors relevant to diagnostic
accuracy. The results promise to transform current thinking about medical image viewing, where current models
typically assume that targets are either completely unknown or are known with exacting precision. The results
will also clarify and resolve long-standing mixed findings in the radiologic search literature: various studies have
found that prior knowledge (e.g., clinical history or cues indicating what abnormalities to search for) either
improves, decreases, or has no effect on diagnostic accuracy; might or might not influence later parts of the
search task (such as time spent identifying an abnormality after looking at it); and either does or does not
increase false alarms. By assessing eye movement dynamics, the proposed project will clarify the underlying
mechanisms driving these effects. In addition, this project will provide opportunities for undergraduate students
to engage in biomedical research and will greatly strengthen the biomedical research environment at NYIT, which
has received limited NIH support to date.

Public health relevance
PROJECT NARRATIVE As Computer Aided Detection systems and Artificial Intelligence tools continue to be integrated into healthcare processes, it is critical that we understand how information provided to professionals alters their behavior, but there is a gap in knowledge concerning how cueing effects alter medical image interpretation. Research suggests that precise text cues are known to result in more efficient search than imprecise cues, but this has only been demonstrated using hue information—which is absent in radiologic search—and the effects of cues on radiologic search are largely unknown (relevant prior studies are inconclusive). This project will fill the gap in knowledge by quantifying, for the first time, whether or not precise cues more efficiently guide eye movements during radiological search.